K+ SUPPLEMENT IN BLOOD PRESSURE AND GLUCOSE TOLERANCE IN NIDDM WITH HYPERTENSION

Interventional study of the effects of potassium supplementation on BP, glu se metabolism and cellular cation transport in subjects with NIDDM and mild-to-moderate hypertension.